The role of hexokinase 2 in liver fibrosis and NASH-induced HCC

Hepatic fibrosis is a major cause of mortality in patients with non-alcoholic steatohepatitis (NASH).
Hepatic fibrosis also plays a major role in the development of hepatocellular carcinoma (HCC,
which is a second leading cause of cancer mortality world-wide. Hepatic stellate cells (HSCs) that
generate hepatic fibrosis are activated by liver injury, but the mechanism of their activation is not
fully understood. Upon activation HSCs start expressing genes such as alpha-smooth muscle
actin (aSMA) and collagen type 1a1 (Col1a1), which are markers of hepatic fibrosis. Upon
activation HSCs become highly glycolytic and consequently produce high level of lactate. Lactate
has been suggested to play a role in regulating gene expression upon HSCs activation, but the
mechanism remains elusive. We found that high glycolysis and lactate production in activated
HSCs is largely due to the induction of hexokinase 2 (HK2) expression. Our results show that
HK2 is required for the activation of HSCs and liver fibrosis. Interestingly, we found that lactate
produced, because of HK2 expression, induces histone lactylation, which is required for gene
expression in activated HSCs. In the absence of HK2 the induction of gene expression is impaired
in HSCs, but lactate could override the effect of HK2 deletion on gene expression. We also found
that HK2 deletion in hepatocytes attenuates NASH-induced hepatocarcinogenesis. Therefore, our
results suggest that targeting HK2 could be therapeutic for both liver fibrosis and NASH-induced
HCC. In this grant application we will further validate the role of HK2 in liver fibrosis and how it
affects NASH-induced HCC. We will employ a mouse model of NASH-induced HCC in which
there is extensive fibrosis. We will use these mice to study the role of HK2 in the interplay between
liver fibrosis and HCC. Finally, as a proof of concept, we will verify if systemic HK2 deletion, which
does not elicit adverse physiological consequences, could inhibit both fibrosis and HCC in a
mouse model of NASH-induced HCC.

Public health relevance
Hexokinase 2 (HK2), which catalyzes the first committed step in glucose metabolism, is not expressed in most normal adult tissues but is induced in cancer cells. We found that HK2 is also induced in activated hepatic stellate cells and is required for fibrosis. The role of HK2 in liver fibrosis and NASH-induced HCC will be explored.